Strengthening Physician Communication about Adolescent Vaccines

DESCRIPTION (provided by applicant): The overarching goal of this proposal is to develop and test a 3-component intervention to improve provider-level communication and recommendation for the HPV vaccine for adolescent patients. Our intervention is based on principals of the Precaution Adoption Process Model and will target provider-patient communication before, during and after the clinical encounter so as to have the potential to impact many stages of parents' decision-making about the vaccine. The intervention will incorporate two tools developed previously by our research team that have been shown in pilot studies to be effective at improving HPV vaccine decision-making. One is VaxFacts-HPV - a web-based educational tool that will be given to parents prior to the scheduled visit that provides them with individually-tailored educational information about the vaccine reflecting each parent's unique concerns, attitudes and beliefs. The second is our Decision Aid for HPV Vaccines that will be given to parents who remain unconvinced about HPV vaccination at the end of the clinical encounter in order to enable them to prioritize their health goals for their children and make decisions about HPV vaccination that align with those goals. The third, and core, component of our intervention is delivered in the clinic by providers. It consists of a provider-developed, clinic-specific, HPV Fact Sheet, combined with enhanced provider communication skills obtained via a specialized communication training session that is based on the principles of Motivational Interviewing. A cluster-randomized controlled trial design will be used to assess the impact of the provider communication intervention package compared to usual practice. Extensive provider feedback will be used to develop the HPV Fact Sheet and the intervention implementation procedures. The Specific Aims of the project are: 1. To assess baseline adolescent vaccination levels and HPV vaccine communication activities among the study practices. We will use a mixed-methods approach to achieve this Aim. 2. To develop in conjunction with provider feedback the in-clinic HPV Fact Sheet, and overall study implementation procedures. A procedure called Process Mapping will be used to develop an implementation plan for the intervention components to optimize their sustainability and acceptability. 3. To implement and assess the impact of the intervention on adolescent vaccine utilization, clinical practice and provider communication. We will assess the impact of the intervention on levels of adolescent HPV vaccination, whether there are spill over affects on the use other adolescent vaccines, and whether it impacts clinical practice and parent perceptions about provider's communication about adolescent vaccines.

Public health relevance
PUBLIC HEALTH RELEVANCE: If our intervention proves efficacious it could have a significant public health benefit by decreasing adolescents' risk for the sequelae from HPV infection. Because our communication-based intervention may impact provider communication about adolescent vaccines more broadly, it may also potentially impact adolescent Tdap, MCV and Flu vaccine utilization. By designing our intervention to facilitate provider-parent communication about vaccines throughout the continuum of the vaccine decision-making process, and incorporating significant provider feedback into the intervention components, our intervention is more likely to be acceptable, feasible and sustainable across a variety of clinical practice types and patient populations. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS The Healthy People 2020 report states a goal of 80% uptake of recommended vaccines among adolescents. While levels of adolescent vaccine utilization have been steadily increasing over the last several years, none of the adolescent-targeted vaccines (which include tetanus-diphtheria-pertussis [Tdap], human papillomavirus [HPV] and meningococcal [MCV4] vaccines) have reached this target coverage level. The rate of HPV vaccine uptake has been shown in national studies to be particularly slow when compared to the other adolescent- targeted vaccines. Reasons for this are multifactorial, but many studies suggest that a primary driver of this phenomenon is the lack of a strong provider recommendation for the HPV vaccine - an effect that is particularly pronounced for 11-12 year olds who are the preferred target age for HPV vaccination. Developing interventions to increase adolescent vaccination, particularly HPV, has become a priority area for research. The overarching goal of this proposal is to develop and test a 3-phase intervention to improve provider-level communication and recommendation for the HPV vaccine for adolescent patients. Our intervention is based on principals of the Precaution-Adoption-Process Model (PAPM) and will target provider- patient communication before, during and after the clinical encounter so as to have the potential to impact various stages of parents' decision-making about the vaccine. The intervention incorporates two tools developed previously by our research team that have been shown in pilot studies to be effective at improving HPV vaccine decision-making. These include "VaxFacts-HPV" which is a web-based educational tool that provides individually-tailored educational information about HPV vaccines to parents that reflects each parents' unique concerns, attitudes and beliefs. VaxFacts-HPV will be provided to parents prior to their adolescent's clinical appointment to raise awareness about the need for the vaccine, address initial questions or concerns the parents may have, and provide a starting point for a conversation about the vaccine with the provider. The second tool is our "Decision-Aid for HPV Vaccination" that will be given to parents who remain unconvinced about HPV vaccination at the end of the clinical encounter in order to enable them to prioritize their health goals for their children and make decisions about HPV vaccination that align with those goals. The third, and core component of our intervention is delivered in the clinic by providers. It consists of a provider-developed HPV "Fact Sheet" that reflects the most relevant discussion points identified by providers about HPV infection and vaccination combined with improved provider communication skills obtained via communication training session for providers to increase their ability to engage with HPV vaccine hesitant parents. Both the Fact Sheet and the specific intervention implementation procedures will be developed with extensive provider feedback to enable the intervention so that it can be individualized for each clinical setting and patient population to improve its effectiveness, acceptability and sustainability. The Specific Aims of the project are: 1. To assess baseline adolescent vaccination levels and HPV vaccine communication activities among the study practices. Baseline vaccination levels and communication activities will be used to ensure balance in these outcomes during the randomization of practices into control and intervention arms for Aim 3. 2. To develop in conjunction with provider feedback the in-clinic HPV Fact Sheet, and overall study implementation procedures. We will use extensive provider feedback to develop the HPV Fact Sheets. These will be tailored to each clinical setting to reflect the HPV discussion points that are most relevant to the providers and the patients they serve. A procedure called "Process Mapping" will be used to optimize the sustainability and acceptability of the intervention. 3. To implement and assess the impact of the intervention on adolescent vaccine utilization, clinical practice and provider communication. We will use a cluster-randomized trial design, with randomization occurring at the clinic level, to assess the impact of our intervention on adolescent HPV vaccine utilization. We will also assess if the intervention creates any "spill over" effects on the utilization of Tdap and MCV vaccines, and whether it impacts clinical practice and parent perceptions about provider adolescent vaccine communication.